Developing a Novel Biologic Therapy to Eradicate Brain Cancer and Brain Metastasis

PROJECT SUMMARY
Brain cancers are the leading cause of disease-related death in children and in adults under the age of 40
years old. Even with aggressive treatments that include maximal surgical resection, stereotactic radiosurgery,
whole-brain radiation therapy, chemotherapy, molecularly targeted therapeutics, and immunotherapies, the
recurrence rates for many brain cancers are nearly 100%. Despite the hundreds of clinical trials and combination
therapies tested, the mortality rates have only slightly decreased. According to the American Cancer Society, it
is estimated that there will be over 24,000 adults and children with primary brain cancer in the US in 2023 with
no available medications that can reverse drug resistant brain cancer recurrences. When secondary brain
metastases from other primary cancers like breast, melanoma and lung are included, it is estimated that there
will be over 300,000 patients with secondary brain metastases this year in the US. These patients are confronted
with a mixed blessing of longer initial treatment survival but an increased incidence of secondary, drug resistant
brain tumors. Much like primary brain cancer, when other cancers metastasize to the brain, they are almost
always lethal. New therapies that can target adult and pediatric drug resistant recurrent primary and secondary
brain cancers are badly needed.
Creative BioTherapeutics, has discovered that recurrent drug resistant cancers up-regulate a survival
pathway resulting in the expression and secretion of an extracellular Glucose-Regulated Protein 78 (ecGRP78)
in the tumor microenvironment. Our research shows that ecGRP78 is important for drug and immune resistance
as well as glioma stem cell formation. Cell surface bound ecGRP78 has been found on breast, lung, ovarian,
prostate, melanoma, multiple myeloma, colon, pediatric and adult brain tumors and not on normal cells. We have
found that ecGRP78 stabilizes essential oncofetal proteins, ROR1 and Cripto, along with the checkpoint protein,
PD-L1, on tumor and immune cell surfaces inducing a cascade of events to increase drug resistance, immune
suppression, and cancer stem cell formation. As such, we designed and developed several anti-cancer therapies
to specifically block the N-terminal domain of ecGRP78 from binding to and stabilizing these pro-tumorigenic
proteins on the tumor surface without disrupting normal cell function. We can now show that our lead inhibitor,
CBT300, in vitro can a) induce apoptosis of drug resistant tumor cells, b) eliminate drug and immune resistance
showing synergistic effects with chemotherapy and immunotherapy, c) decrease the amount of chemotherapy
needed, thus lowering the toxic side effects. Our in vivo results with human high grade glioma tumors in mice
treated with one of our ecGRP78 inhibitors displayed an increase in pathological complete responses of over
65% and an increase in median survival of 12 days or an estimated 2 years for human patients with no observable
toxicity. A non-toxic therapeutic alternative effective against recurrent brain tumors and brain metastasis
with increased overall survival and complete responses would prove to be paradigm altering.

Public health relevance
PROJECT NARRATIVE Current therapies attempting to regress and cure brain tumors and brain metastases have failed due to drug and immune resistance from glioma stem cells which our research shows are highly associated with extracellular GRP78. Our overall goal for this NIH SBIR Phase I proposal is to further our proof-of-concept experiments with our patented anti-cancer GRP78 inhibitors establishing a lead candidate as an effective therapy for patients with pediatric and adult brain tumors and brain metastasis. A therapeutic alternative that is non-toxic and is effective at targeting this extracellular GRP78 in recurrent brain tumors and brain metastasis resulting in a significant increase in overall survival would prove to be paradigm altering.